Scholars in Oncology Associated Research (SOAR)

Project Summary/Abstract
With the increasing complexity of cancer care, the rising numbers of diverse cancer survivors in the US
population, and the increasing global burden of cancer, it is critical that Pritzker School of Medicine (PSOM)
prepare a workforce trained to meet these challenges. Workforce for the continuum of care from risk
assessment and prevention, early detection, treatment, survivorship and end of life care is interdisciplinary and
inter-professional but medical education has remained compartmentalized. We aim to transform our approach
to training medical students at PSOM for 21st Century cancer care by developing the Scholars in Oncology
Associated Research (SOAR) program. In a new highly innovative 11-week intensive summer program
for medical students, SOAR participants will learn fundamentals of cancer research along with interdisciplinary
and interprofessional cancer care. The program will enroll twelve medical students each year, including four
students who will conduct global cancer research at established UChicago Global partner sites. Each student
will conduct interdisciplinary cutting-edge cancer research in with strong mentorship by established NIH
funded investigators in our Comprehensive Cancer Center or the Center for Global Health. In addition,
trainees will take part in formal instruction in responsible conduct of research, didactic lectures on the science
of oncology, interdisciplinary tumor boards, research skill development and career planning activities as well as
opportunities for career exploration, networking, and outreach that will increase their knowledge of cancer and
motivate them to pursue further education and training for future careers as cancer researchers. Trainees will
be supported by a tiered mentorship structure that includes Faculty Cluster Group Leaders who will be
responsible for monitoring progress along milestones of completing their projects and lead peer mentoring
sessions where they learn about each other's research. Using didactic sessions, experiential research training
in diverse settings that represent the diversity of cancer research, and formal exposure to national and global
leaders in oncology research across the care continuum, SOAR participants will have a greater appreciation
for research training in the context of the interdisciplinary and interprofessional oncology care. With rigorous
evaluation and planning, we will continue to improve SOAR and determine if SOAR participants show a greater
propensity to pursue cancer research and/or pursue oncology as a career, as well as track long-term outcomes
such as publications, grants, and entry into academic careers. The SOAR program aims to inculcate the next
generation of cancer researchers with the desire to understand and improve quality of cancer care through
pursuit of research intensive careers in Academia, Industry, Government or private Health Systems. SOAR will
enable PSOM to maintain its tradition of excellence in preparing a diverse and highly skilled workforce to
achieve the promise of precision oncology care and promote global health equity.

Public health relevance
Project Narrative The Scholars in Oncology-Associated Research (SOAR) training program is a 11-week intensive structured mentored cancer research experience in basic science, clinical or population research along with didactic seminars covering the cancer care spectrum and experiential training in the interdisciplinary and interprofessional care of patients with cancer in diverse settings. SOAR aims to inculcate intellectually curious medical students with the desire to pursue research intensive careers in the future.